Hybrid Peptides as Autoantigens for Diabetogenic CD4 T Cells

Abstract
This competing renewal application is to continue our studies on the role of hybrid insulin peptides (HIPs) as
neo-epitopes for autoreactive CD4 T cells in autoimmune diabetes. During this very productive period we
have established that HIPs formed from insulin C-peptide and other β-cell granule proteins are antigens for
large numbers of autoreactive CD4 T cells in the pancreas of NOD mice, can be used in strategies to
induce antigen-specific tolerance, and are also present in human islets and PBMC of patients with type 1
diabetes (T1D). Our objective in the next period of the award will be to characterize new insulin (Ins) B-
chain HIPs and T cells reactive to these HIPs, in both NOD mice and human subjects. We hypothesize that
antigenicity of the much studied insulin B chain peptide, B:9-23, is due to hybrid peptide formation between
sequences of B:9-23 and cleavage peptide products of other granule proteins. The rationale for pursuing
these studies is based on preliminary data indicating that B-chain HIPs containing B9-23 sequences are
strong agonists for insulin-reactive T cell clones and that T cells reactive to these HIPs can be identified in
the polyclonal T cell population of NOD mice. Our aims for this next project period are to (1) investigate the
role of B-chain HIP-reactive T cells in disease pathogenesis; (2) determine whether tolerance can be
induced with insulin B-chain HIPs coupled to biodegradable nanoparticles in NOD models of spontaneous
disease and islet transplantation; and (3) investigate the presence of B-chain HIP-reactive CD4 T cells in
human T1D and develop new human tetramers containing B-chain HIPs. The B-chain HIPs will provide
further tools for understanding the autoimmune response to pancreatic β-cell antigens in general, and
specifically the contribution of insulin-reactive T cells to the disease process. We predict that these studies
will lead to generation of reagents not only for tracking disease-relevant T cells, but also for developing and
expanding approaches to antigen-specific therapy.

Public health relevance
Project Narrative The goal of this project is to determine the role of a new type of hybrid insulin peptide (HIP) containing insulin B-chain sequences. Discovery and characterization of B-chain HIPs and B-chain HIP-reactive T cells will be carried out in the Non-Obese Diabetic (NOD) mouse model of autoimmune diabetes. We will investigate whether B-chain HIPs can be used to induce antigen-specific tolerance in NOD diabetes and the presence of T cells reactive to B-chain HIPs in human T1D patients to develop new tetramers for tracking these T cells.